Clinical and implementation outcomes of a point of care sexually transmitted infection testing strategy to improve HIV prevention service delivery in adolescents

PROJECT SUMMARY/ABSTRACT
While Centers for Disease Control and Prevention clinical practice guidelines recommend delivering HIV
prevention services to all adolescents seeking sexually transmitted infection (STI) testing and treatment, only
55% of youth seeking STI care receive HIV testing and 8% are counseled on HIV pre-exposure prophylaxis
(PrEP). These gaps in service delivery have persisted over the last decade, despite both STI rates being at an
all-time historic high in adolescents and HIV disproportionally affecting adolescents and young adults.
Innovative implementation strategies—discrete tools and practices to close evidence to implementation gaps—
are needed to enhance HIV testing and PrEP delivery in adolescents. One such strategy is point of care testing
(POCT) for gonorrhea and chlamydia (GC/CT), which delivers test results within 30 minutes, rather than the
standard 2-3 days for laboratory-based testing. The first GC/CT POCT device was approved by the Food and
Drug Administration in 2021, but, as yet there are no clinical or implementation outcome data for GC/CT POCT
in routine pediatric settings. This new testing modality can increase opportunities for delivery of HIV testing and
PrEP services by heightening HIV risk perception for patients and clinicians and allowing adolescents same-
day access to HIV prevention services when they are already in clinic. The proposed research will test our
overarching hypothesis—that GC/CT POCT will improve HIV testing, PrEP counseling, and PrEP
delivery and be a feasible, acceptable, and appropriate implementation strategy in adolescents seeking
STI testing in pediatric settings—through a pragmatic pilot feasibility trial. Leveraging funding for the POCT
equipment and supplies provided through a Penn Centers for AIDS Research equipment grant, in Aim 1, we
will use a phased implementation design to assess population and patient-level associations between test
modality (POCT versus laboratory-based) through analysis of electronic health record data from patients
seeking STI testing (n~12000) at three diverse adolescent health clinics. We will use causal inference
methods, including interrupted time series analysis and inverse probability regression adjustment, to
strengthen the rigor of our statistical models. In Aim 2, we will conduct an embedded mixed methods study
using surveys and semi-structured interviews grounded in the Health Beliefs Model and Consolidated
Framework for Implementation Research to assess determinants and outcomes of feasibility, acceptability, and
appropriateness of POCT as an HIV prevention implementation strategy in clinicians and clinic staff (n~40) and
adolescent patients (n~175). We will integrate these data into an Implementation Research Logic Model that
will guide design of a Type II effectiveness-implementation trial. This R21 will provide critical funding to support
this clinical and implementation outcomes research, which will yield foundational data to inform a large-scale
trial testing the clinical effectiveness of GC/CT POCT, paired with various implementation strategies identified
in this R21 research, as a strategy to improve HIV testing and PrEP delivery outcomes in pediatric settings.

Public health relevance
PROJECT NARRATIVE While point of care testing for gonorrhea and chlamydia, which delivers results in ~30 minutes, is a promising strategy to improve HIV testing and pre-exposure prophylaxis (PrEP) delivery in adolescents and young adults, there are currently no clinical or implementation outcomes data for this novel technology in routine pediatric healthcare settings in the United States. The proposed research hypothesizes that point-of-care STI testing for sexually transmitted infections will be a feasible, acceptable, and appropriate implementation strategy for improving HIV testing and PrEP delivery in youth, by increasing opportunities for clinician-patient counseling, decreasing loss to follow up, and allowing for same-day HIV prevention service provision. We will test this hypothesis in a pragmatic non-randomized trial comparing clinical (HIV testing and PrEP counseling and prescription) and implementation (feasibility, acceptability, and appropriateness) outcomes between adolescents receiving point of care testing compared to laboratory-based testing at three clinics within a large pediatric health system.